Transcriptional regulations underlying cell type specific terminal differentiation of cortical interneurons

Project Summary/Abstract
Cortical inhibition provided by GABAergic interneurons (INs) plays a key role in both normal brain function and
pathogenesis of several brain disorders such as schizophrenia, autism, epilepsy as well as injury-induced brain
dysfunction such as chronic pain. Cortical INs (cINs) comprise a variety of subtypes that differ in morphology,
electrophysiological properties, connectivity, gene expression, and circuit/behavior functions. Diverse modes of
inhibitory regulations mediated by different cIN subtypes are necessary for the integrity of the cortical inhibitory
function. Therefore, elucidating the genetic mechanisms underlying cIN diversification is imperative for not only
understanding the origin of cIN functional diversity but also developing cell type specific treatments using drugs
and stem cells. However, the transcriptional basis for cIN subtype specification remains poorly understood.
The objective of our proposal is to characterize the expression of candidate cell type preferential TFs
and determine their essential role in the synaptic organization of the cIN subtype during postmitotic
terminal differentiation by in vivo functional screening. To achieve this goal, we will perform a series of
experiments using the chandelier cell (ChC), which exclusively innervates axon initial segments of pyramidal
neurons (PNs) and thus powerfully controls spike generation in PNs.
The stereotypy of the axonal/synaptic organization makes ChCs ideal for studying development of cIN
subtypes. Our published and preliminary studies identified TFs and CAMs that are predominantly expressed in
postmitotic ChC precursors and showed that some of these CAMs critically control ChC synaptic development
and specificity. Based on these results, we propose to test the hypothesis that ChC preferential TFs
postmitotically control the synaptic organization characteristic of ChCs. We will pursue the following specific aims
to achieve the above objective. To ensure feasibility for the proposed experiments, we developed in vivo genetic
strategies that allow us to reliably manipulate murine young postmitotic ChCs as well as a single cell genotyping
approach that links genotypes to phenotypes in ChCs subjected to genome editing. In Aim 1, we will characterize
the expression of the ChC preferential genes identified by bulk RNA-seq, at single cell levels during postnatal
development. In Aim 2, we will identify TFs that postmitotically control the ChC synaptic organization.
Our study will unravel the transcriptional basis for the cell type specific cIN synaptic organization and provide
an entry point into understanding the transcriptional principle of postmitotic cIN terminal differentiation. The
genetic insight into cell type specific cIN terminal differentiation obtained from this study will ultimately serve as
a foundation for differentiating human pluripotent stem cells into specific cIN subtypes, which will benefit a cell
transplantation-based therapy and drug discovery.

Public health relevance
Project Narrative GABAergic inhibitory interneurons play a key role in normal brain function as well as pathogenesis of brain diseases/dysfunction such as schizophrenia, autism, epilepsy, and chronic pain. Although the functional integrity of cortical inhibition is supported by a variety of interneuron subtypes that differ in morphology, physiology, connectivity, and gene expression, transcriptional regulations underlying interneuron diversification remains poorly understood. Our study will identify transcription factors that are necessary for terminal differentiation of a cortical interneuron subtype, which will serve as a foundation for obtaining human pluripotent stem cells derived interneuron subtypes that should benefit a cell transplantation-based therapy and drug discovery.